Multiplexed dissection of metastatic ability, organ tropism, and immune evasion

ABSTRACT
Pancreatic ductal adenocarcinoma (PDAC) is a frequent and almost uniformly fatal malignancy. PDAC
metastasizes to many different organs and is largely refractory to conventional chemo- and immuno-therapies.
PDAC cells exist in diverse cell states, however, the extent to which these states dictate metastatic ability, organ
tropism, and immune evasion remains largely unexplored. The critical molecular drivers underlying metastatic
fitness phenotypes that drive success at each step of the metastatic cascade are likely highly diverse and remain
largely unknown. To bridge this knowledge gap, we will integrate genetic barcoding with single cell profiling to
uncover the determinants of the fundamental properties of metastasis. We are uniquely positioned to conduct
this multidisciplinary systems-level proposal which employs innovative methods for multiplexed dissection of the
metastatic process. We will employ molecular barcoding and high-throughput barcode sequencing to quantify
the metastatic ability of an extensive panel of >30 PDAC cell lines across time, organ site, and immune
environment. Our preliminary data from our pooled and barcoded cell line panel demonstrate highly
heterogeneous metastatic phenotypes and cell states, and that our approach provides both cell line-level and
clonal resolution of metastatic ability. In Aim 1, we will pool our barcoded cell lines for several types of
transplantations that mimic modes of metastatic spread and quantify the metastatic ability of highly diverse cell
states across different time durations, organ sites, and immune environments. Similar approaches will be
employed to investigate cancer adaptation for immune evasion. In Aim 2, we will relate metastatic phenotypes
to the molecular programs underlying diverse cell states and determine how cell state influences metastatic
fitness and immune evasion. By performing scRNA-seq on the multi-component barcode in our cell lines
following intrasplenic and intravenous injection at multiple time points and immune environments, we will
determine the cell states that confer selection for successful metastasis and adaptation to immune response. In
Aim 3, we will investigate key regulators of metastatic phenotypes using multiplexed functional approaches. We
will prioritize genes that are highly expressed or strongly induced in cell lines with enhanced metastatic ability
and inactivate each candidate driver of metastasis in each cell line. By transplanting this pool of genetically
altered cell lines, followed by Perturb-seq, we will determine the impact and transcriptional effects of each
candidate driver on metastatic ability and organ tropism. Our study will uncover fundamental determinants of
PDAC metastasis using comprehensive and systems-level approaches.

Public health relevance
NARRATIVE PDAC cells exist in diverse cell states, however the extent to which these states dictate metastatic ability, organ tropism, and immune evasion remains largely unexplored. We will integrate genetic barcoding, single cell profiling, and CRISPR/Cas9 genomic editing to uncover the determinants of metastatic seeding, growth, organ tropism, and immune evasion. This analysis will relate metastatic phenotypes to molecular program and uncover fundamental determinants of PDAC metastasis using innovative, comprehensive, and systems-level approaches.